Administrative Supplement: Ambystoma Genetic Stock Center

PROJECT SUMMARY
The Ambystoma Genetic Stock Center (AGSC) is a P40 Research Resource that distributes
laboratory axolotls (Ambystoma mexicanum) to researchers and educators nationally and
internationally. The AGSC houses approximately 880 adults and several thousand
larvae/juveniles in aquatic recirculating systems and static bowls to sustain a captive, wildtype
breeding population and a growing number of mutant and transgenic lines. To ensure the health
of axolotls within the AGSC and their reproducibility in biological experiments it is necessary to
follow rigorous husbandry guidelines. The most critical variable in axolotl husbandry is water
quality. Water quality must be extremely high to ensure normal axolotl development, growth and
reproductive capacity, and to eliminate disease risks associated with pathogens. The AGSC
maintains high water quality by ensuring a constant and readably available water supply and
rigorous sanitary procedures to ensure the cleanliness of bowls and tanks. Tank and bowl
sanitation is a labor-intensive process that is primarily done by hand, and to a lesser extent
using an outdated, commercial restaurant dishwasher that is rapidly becoming non-functional.
This Administrative Supplement will be used to purchase two Calypso - Aquatic Cabinet Washer
systems that are designed to efficiently and effectively clean biological agents and associated
biofilms from aquatic organism tanks and bowls. The addition of these new washer systems will
provide infrastructure that is critically needed to maintain high water quality and sanitary
procedures, increase efficiency of axolotl husbandry, and generate healthy and reproducible
axolotl lines for biomedical researchers.

Public health relevance
PROJECT NARRATIVE Living stock resources are needed for the Mexican axolotl so that investigators can develop research models and translate biological information that is relevant to human health and disease. The Mexican axolotl is a primary vertebrate model for organ regeneration, tissue repair, and post-embryonic development.